Expanding CRISPR-Cas editing technology through exploration of novel Cas proteins and DNA repair systems

Expanding genome editing tools through exploration of new CRISPR-Cas proteins and
DNA repair enzymes
ABSTRACT
The current toolkit for human genome editing could be dramatically expanded through exploration
of new CRISPR-Cas proteins that have yet to be characterized, and through the development of
enzymatic tools to enable controlled repair of DNA breaks. We aim to advance the science and
technology of genome editing by discovering and harnessing new CRISPR-Cas and related
systems through a combination of bioinformatics and biochemistry.
First, we will expand the diversity of CRISPR-CasX and -CasY sequences and analyze associated
proteins, cofactors and small RNAs that contribute to the function of CasX and CasY enzymes.
We will define the organization and functional components of these genomic loci, and conduct
experiments with reconstituted systems that will establish mechanisms of action and enable
testing in mammalian cells. Second, we will determine the mechanism of CRISPR-CasZ proteins,
a newly discovered superfamily of RNA-guided enzymes. These proteins are exceptionally small,
diverse, and have currently undefined functionalities for manipulating genomic sequences. Third,
we will use protein family analyses that leverage huge datasets from uncultivated microbes and
transcriptomics to discover and evaluate new enzymes for DNA manipulation, including helicases,
nucleases, polymerases and recombinases. New gene variants will be identified based on protein
family affiliation, functional predictions and genomic neighborhoods. We will establish assays for
determining molecular activities including DNA and RNA binding, unwinding and cleavage.
Together, the results to be obtained from these aims will lead to new insights into the functions of
known proteins within CRISPR-Cas systems, and will likely uncover new kinds of proteins,
enzymes and transcripts that contribute to genome surveillance and manipulation across the
microbial world. This will lead to a much larger toolbox for genome editing than is currently
available, enabling researchers and clinicians to quickly optimize technologies according to their
needs.

Public health relevance
Expanding genome editing tools through exploration of new CRISPR-Cas proteins and DNA repair enzymes NARRATIVE Fundamental research on bacterial adaptive immunity uncovered the genome editing properties of CRISPR-Cas systems, and it is clear that uncultivated microbes contain more pathways and enzymes that may be useful as genome editing tools. We will combine bioinformatics and biochemistry to identify new DNA- and RNA-associating proteins and will analyze their mechanisms of action. We will focus our investigation on newly described CRISPR-Cas systems and DNA-interacting proteins that occur in conserved genomic context.